Vestibular Oriented Research Meeting

Project Summary/Abstract
We propose that the 2025 Vestibular Oriented Research Meeting will be held on the University of Colorado
Anschutz Medical Campus in Aurora/Denver, Colorado on June 23-26. The overall goal of this meeting is to
enhance collaborative efforts and drive better understanding of the function of the vestibular system. This
meeting will bring together a diverse range of vestibular experts from around the world – including audiologists,
basic scientists, neuroengineers, neurologists, neuroscientists, otologists, occupational therapists, and physical
therapists. These experts will come from the communities of government and academic scientists. Building upon
the successful meetings in 2019, 2021 (virtual), and 2023, the focus of the 2025 meeting will be on all aspects
of vestibular function, including but not limited to (a) mechanisms and anatomy of the vestibular periphery, (b)
information processing, (c) visual-vestibular integration, (d) behavioral research, including vestibulo-ocular
reflexes and balance, (e) aging, and (f) vestibular systems modeling and neuroengineering. We intend to
continue following the 2025 meeting, with a meeting every other year (e.g., 2027, 2029, etc). Objectives of our
meeting series are to (i) promote a sense of community (ii) foster scientific discussions and interactions, (iii)
support young investigators and participant diversity, and (iv) encourage collaborative research (e.g., sharing of
unique resources like some of those at the Naval Medical Research Unit in Dayton). Successful attainment of
our objectives will greatly enhance the pace, direction, and completion of rigorous vestibular-centric research,
the discoveries of which could lead to seminal evidence necessary to move the field forward. The meetings will
offer trainees (students and post-doctoral fellows) funding to offset conference attendance and
participation-related costs, providing an opportunity to discuss their work, develop new ideas, and network not
only with other junior investigators, but also with senior scientists, providing an unique collegial environment for
professional growth. The 2025 meeting is co-organized by researchers from the University of Colorado-Boulder
(PI Dr. T. Clark), the University of Colorado-Anschutz (Drs. K. Rennie and J. Hebert), and the Ohio State
University (Dr. D. Merfeld). In addition, as in prior meetings, we will have a diverse group of 6-8 planning
committee members. The Anschutz Medical Campus provides an outstanding co-located scientific and clinical
setting to encourage the intense invigorating discussions planned for this collegial gathering, in addition to
providing a distinctive opportunity to visit world-class vestibular research laboratories and clinical facilities.

Public health relevance
Project Narrative The vestibular system – the receptors in our inner ear that sense motion and orientation and their associated neuronal connections – makes fundamental contributions to autonomic regulation, balance, spatial orientation, and visual acuity during motion; its impairment is common and can be severely debilitating. Despite its fundamental significance, vestibular function remains poorly understood – in part, because there is no single meeting that brings together the entire vestibular research community. Our Vestibular Oriented Research meeting will bring together leading and aspiring vestibular researchers from around the world to (a) share and build knowledge, (b) help unify our diverse transdisciplinary specialty, (c) transform interactions within our vestibular research community and (d) improve interactions with independent and/or parallel disciplines (e.g., aging, audiology, neuroengineering, neurology, neuroscience, otology, physical therapy, and vision) that include substantial overlap with one or more of the various vestibular sciences.